Core C: Cell Models Core

To support development of novel therapies for Cystic Fibrosis (CF), the Cell Models Core (Core C) of the
University of North Carolina (UNC) CF Research and Translation Core Center provides multiple services and
resources. These are available to UNC CF Center members, to other local investigators, and to the national and
international CF translational medicine communities. As well as our traditional strengths providing normal and
CF human and mouse airway epithelial cell air liquid interface cultures in systems reproducing important
elements of the airway in vivo, we have responded to changing needs and priorities, providing enhanced
resources for GI research, including intestinal organoids, planar intestinal epithelial cell preparations, and
esophageal and pancreatic epithelial cells. We support the “conditionally reprogrammed cell” technique for small,
minimally invasive specimens, directed differentiation of induced pluripotent stem cells, genetic manipulation of
primary cells for mechanistic studies and creation of novel cell lines. A fee-for-service Recharge for Service
Center (RSC) for more convenient and wider provision of Core C services has been established. We are
philosophically committed to widespread translation of non-proprietary technology locally, nationally and
internationally by providing training and cell procurement and characterization services to outside suppliers of
tissue specimens. The Cell Models Core, along with the other Cores in this proposal, will facilitate rapid, rigorous
and reproducible research and pre-clinical testing necessary to overcome the significant barriers of bench to
bedside translation of novel CF therapies.